Origami Nanoprobes for Large-Scale Single-Cell Analysis of Lymphocytes

Project Summary/Abstract Next generation sequencing platforms have revolutionized modern approaches for understanding a wide variety of biological processes, including immune responses and cancer. However, increasing evidence shows that the diversity of the cells involved in these processes has important implications for understanding biologic outcomes. For instance, the diversity of T cell receptors on lymphocytes during responses to virus or cancer can have dramatic effects on disease outcome. Conversely, the diversity of cancer cells has important implications for successful control of disease. Therefore, a critical hurdle in these situations is the ability to provide single-cell analysis techniques coupled with high-throughput next generation sequencing, to adequately measure the diversity of cells. Unfortunately, current single-cell analysis approaches are either unfeasible for large cell populations, too expensive, and/or require specialized equipment that is not available to most labs while bulk sequencing approaches provide no information on individual cells. To address this problem, we have engineered DNA origami nanostructures that are able to specifically bind and protect two different mRNA within transfected cells, and used DNA origami-specific matching barcodes upstream of capture sequences to generate to identify in HT-NGS output sequences which sequences came from the same nanostructure and therefore from the same transfected cell. In this proposal we develop this approach for quantitating the diversity of clonally-distributed TCRα and TCRβ T cell receptors in human T lymphocyte populations and directly compare the throughput, efficiency, cost and error rates to both conventional bulk- sequencing and single-cell sequencing approaches. We have previously developed this approach for analysis of mouse TCR pairs from primary T cells, and expect little difficulty in adapting this modular platform to human T cells. This technology will be useful for downstream application to a wide variety of biologic processes, by relatively simple modifications to the DNA origami nanostructure probe sequences, including single-cell analysis of other diverse lymphocyte populations, including other T cell subsets or antibody producing B cells, as well as single cells analysis of heterogeneous tumors or diverse microbial communities. Moreover, because this approach utilizes equipment found in most modern molecular biology laboratories, it could be easily adopted by many researchers for these analyses.

Public health relevance
Project Narrative Gemneo Biosciences has developed a novel approach for obtaining single-cell sequence information on gene pairs while maintaining the high-throughput, low-cost, and high-efficiency of bulk sequencing approaches. We will apply this method to analysis of human TCR/ pairs from primary cells, and directly compare the cost, efficiency, throughput, and error rates to conventional single-cell RNA or bulk DNA analysis methods. This will facilitate rapid transition to market with product for analysis of TCR in a multitude of immune-oncology projects.